Brown Adipose Tissue and Sleep Regulation

DESCRIPTION (provided by applicant): The interactions between sleep and metabolism have been described in health and disease; however, the mechanisms and tissues mediating this interplay remain unclear. Brown adipose tissue (BAT) plays a critical role in maintaining metabolic homeostasis by regulating energy expenditure, glucose disposal and heat production. Brown fat has become the focus of intensive research after the detection of functional BAT in human adults five years ago; this recent advance makes the proposed research particularly timely. BAT activation is associated with the suppression of body weight and with a healthy metabolic phenotype. Loss of BAT function is linked to multiple metabolic disorders, such as obesity and type 2 diabetes. The long-term goal is to identify the mechanisms that underlie the reciprocal relationship between sleep and sleep loss on the one side, and metabolism and metabolic disorders on the other. The goal of this proposal is to investigate a novel peripheral mechanism of sleep signaling in which the metabolic activity of BAT plays a central role. The central hypothesis is that sleep loss increases sympathetic outflow to BAT and stimulates the alternative activation of resident macrophages in BAT leading to increased BAT thermogenesis. BAT heat production, in turn, facilitates recovery sleep after sleep loss via the activation of the nucleus tractus solitarius (NTS). The central hypothesis is based on preliminary studies demonstrating that sleep loss activates BAT thermogenesis which is critical for the subsequent recovery sleep. Three specific aims will test the central hypothesis. Specific Aim 1 will identify the mechanisms of sleep loss-induced BAT activation. We will determine the role of sympathetic efferents and alternatively activated (M2) macrophages. Specific Aim 2 will determine the contribution of BAT sympathetic nerves and M2 macrophages to sleep and metabolic responses to sleep loss. Specific Aim 3 will determine the role of NTS in the somnogenic signaling from BAT. The approach is innovative because it focuses on a novel mechanism through which sleep and the metabolic activity of a peripheral organ are reciprocally connected. Sleep loss is associated with increased risk of obesity, diabetes, cardiovascular diseases, cancer, as well as increased all-cause mortality. It impairs cognitive and behavioral performance posing a significant burden to society in terms of property damage, lost productivity, personal injury, and death. The proposed research is significant, because understanding the physiological mechanisms that underlie recovery from sleep loss will lead to new treatment strategies to prevent negative health outcomes associated with poor sleep.

Public health relevance
PUBLIC HEALTH RELEVANCE: The proposed work is relevant to public health because it focuses on understanding the mechanisms of metabolic changes caused by sleep loss and the role of altered metabolism in the recovery process from sleep loss. This knowledge will open new avenues towards future translational studies to prevent and treat metabolic and other diseases associated with short sleep and circadian disruptions. Thus the proposal is relevant to the part of NIH's mission that pertains to developing fundamental knowledge that will help reduce the burdens of human disability.